Horizontal cell signaling in the mammalian retina

The photoreceptor synaptic complex is of great importance as it is a key site for the processing of visual
signals, and the transfer of these signals from photoreceptors to downstream neurons in the retina. The focus
of this application is on horizontal cells, inhibitory interneurons that send feedback inhibition to photoreceptors,
feedforward inhibition to bipolar cells, and autaptic signals to themselves. The prevailing view of horizontal cell
function is that these cells mediate lateral inhibition between photoreceptors, contributing to the antagonistic
receptive field surrounds found in downstream neurons. However, the cellular mechanisms underlying the
contribution of horizontal cells to receptive field properties in mammalian bipolar and ganglion cells has proven
quite difficult to determine due in major part to the lack of fundamental information on horizontal cell signaling.
The objective of this program is to understand visual processing in the retina with a focus on the synaptic and
cellular mechanisms that underlie the initial stages of vision. We will address this objective by determining and
testing the synaptic and cellular mechanisms mediating horizontal cell signaling via GABA to photoreceptors
and bipolar cells, as well as to themselves.
Specific Aim 1: Determine the mechanisms mediating horizontal cell signaling to photoreceptors.
Experiments will test how horizontal cells mediate signaling to photoreceptors by A) identifying the complement
of tonic GABAAR and GABACR subunits expressed by horizontal cells and B) characterizing the indirect
action of GABA on inhibition and disinhibition of photoreceptor Cav channels. Specific Aim 2:
Determine the mechanisms mediating horizontal cell feedforward signaling to bipolar cells.
Experiments will test how horizontal cells provide tonic GABA-mediated signaling to bipolar cell types by A)
identifying the complement of tonic GABAAR and GABACR subunits expressed on the dendrites of ON-
and OFF-bipolar cells and B) characterizing the physiological properties of the GABAergic signal
provided by optogenetically controlled horizontal cells to bipolar cells. Specific Aim 3: Determine the
functional influence of horizontal cell signaling on bipolar cell visual processing. Experiments will
test how features of the light responses of representative bipolar cell types are shaped by horizontal cell
signaling using HaloTagTM and AMPA-DART, a novel chemogenetic tool to silence horizontal cell output.
Proposed studies will further the understanding of fundamental processes mediating early vision. This
objective is consistent with the health-related goals of the National Eye Institute for the understanding of retinal
circuits and the development of therapeutic approaches and diagnostic tools essential for the treatment and
prevention of retinal disease.

Public health relevance
Horizontal cells modulate the transfer of visual information from photoreceptors to second order retinal neurons in a process that is critically important for optimizing visual image analysis over a broad range of ambient light conditions. Proposed studies will test conventional and novel synaptic and extrasynaptic mechanisms underlying horizontal cell inhibitory actions on photoreceptors and bipolar cells to define both feedback and feedforward signaling pathways. This knowledge is a prerequisite for understanding normal retinal structure and function, interpreting diagnostic assessments to detect retinal pathology, and for developing therapies to prevent or restore vision loss due to retinal disease.